Science and Technology Competency and Education Core

The Science and Technology Competency and Education (STCE) Core will incorporate the elements that were fruitful in previous cycles with novel activities in the implementation of knowledge and experiences in entrepreneurship (business creation, intellectual property) and data science. The STCE Core will continue with implementation of research and training opportunities for STEM students and faculty at the PR-INBRE network but will go beyond the current training in traditional scientific presentations and publication processes to augment their development as entrepreneurs and data scientists. To implement this plan, the STCE Core will provide access to academic research, as well as technical and business training to create educators, researchers, entrepreneurs, and data scientists in biomedical and biotechnology-based programs in academia, government institutes and agencies, and biopharmaceutical and biotechnology companies in Puerto Rico and the US. Our Mission is to strengthen the science, technology, entrepreneurship, and data science competencies of the current and future STEM workforce through education and training programs. The STCE Core will also foster collaborations among investigators, entrepreneurs, and data scientists at network institutions, between PR-INBRE researchers in Puerto Rico and other IDeA states, and with COBRE investigators, by supporting travel for collaborative research, scientific meetings, and appropriate training opportunities at IDeA states. Our Vision is to fully develop biomedical research in Puerto Rico into a sustainable enterprise. Reinforcing research, entrepreneurial, and data science skills of our biomedical workforce will contribute to retaining and attracting world-class investigators and entrepreneurs. This strategy is expected to educate a new generation of scientists with additional competencies in research commercialization as well as promote greater financial investment in the local economy. Moreover, we will train our scientists to fulfill the opportunities that are arising in data science to analyze the ginormous amount of information that is being gathered in the scientific and biomedical world. Therefore, we will be pioneers in embarking on training and nurturing young scientists to pursue not just the traditional path in academia, where opportunities are dwindling, but also to have the necessary know-how to pursue alternative career paths. The STCE will thus provide the necessary educational opportunities, mentoring, and financial support to train the undergraduate and graduate student body in the PR-INBRE to create a new cadre of STEM achievers.